Neural Mechanisms of Olfactory Pattern Recognition

ABSTRACT The olfactory system encodes and analyzes odorants. Chemicals bind to members of large families of receptor proteins tuned to different chemical features. While we have a comprehensive inventory of the receptor genes that underlie olfactory detection, we are far from having a similarly comprehensive understanding of the chemical features detected by olfactory systems. This proposal leverages four developments—the ability to record the output of an entire olfactory system (the vomeronasal system), a large and structurally-rigid class of odorants (sulfated, carboxylated, and glucuronidated steroids), a new tool to identify the receptor gene(s) that have particular ligand detection profiles, and a new tool for ectopically expressing a chosen receptor gene and studying its function—to develop the first system-wide understanding of how an olfactory system represents the chemical world. The overarching goal is to develop insights analogous to (and with similar predictive power to) the role of cone photoreceptor tuning curves in our understanding of color vision. The specific aims of the proposal are (1) to reveal relationships between receptor sequence and odorant structure by deorphanizing a large subfamily of vomeronasal receptor genes; (2) to reveal new principles of combinatorial coding through a system-wide analysis of the vomeronasal system's coverage, redundancy, and specificity via a large ligand screen and quantitative analysis of the structural features required for activating each receptor; and (3) to identify mechanisms by which sensory experience shapes sensory neuron tuning. Preliminary data suggest that structural rigidity of steroid metabolites contributes greatly to the tractability of these aims, supporting quantitative and predictive analysis on a system-wide scale.

Public health relevance
PROJECT NARRATIVE Approximately one-third of pharmaceuticals target a single large class of proteins, the G-protein coupled receptors. This same receptor superfamily is used by olfaction to detect chemicals. This proposal aims to develop a system-wide understanding of the relationship between receptors and the chemicals they detect, and may lead to new principles for understanding how to model or target these receptors.